Pharmacokinetics and Toxicology DRF Studies - Blackthorne LDT

This Task Order will be awarded under NIH Blueprint for Neuroscience Research Program, entitled, “Pharmacology and Toxicology for Therapeutics Program (PTTP)”.